Defining the role of Tox3 in congenital cerebellar hypoplasia and ataxia

PROJECT SUMMARY / ABSTRACT
The cerebellum is an exquisitely laminated structure regulating the balance, voluntary motor coordination and
modulating language and cognition through connections with the forebrain. Sitting just under the forebrain,
cerebellum is estimated to contain roughly 80% of the neurons in the human brain. Accordingly, cerebellar
dysgenesis, pathology, or dysfunction is associated with a host of diseases or disorders, including ataxia,
autism, and intellectual deficit. Most cerebellar neurons are a subtype called cerebellar granule cells (CGCs),
which are generated embryonically from a structure termed the rhombic lip (RL)—a germinal zone residing at
the interface between the ventricular zone (VZ) and roof plate of the fourth ventricle. The mechanisms leading
to the specification of the RL germinal niche and subsequent generation of granule cells remain incompletely
understood. Specifically, the epigenetic and transcriptomic changes underlying how the ventricular zone
precursor cells choose the to become RL are largely unknown. We have generated a novel conditional
knockout (cKO) mouse for Tox3, a member of the TOX family of transcription factors previously associated
with the regulation of epigenetics in T Cells. Loss of TOX3 prior to RL specification leads to almost complete
agenesis of CGCs and 100% penetrant ataxia. We hypothesize that TOX3 mediates an epigenetic switch
necessary for the generation of cerebellar granule cell precursors from the rhombic lip and associated
ventricular zone—the loss of which results in developmental ataxia. Using our mature bioinformatics
pipelines and single-cell approaches in combination with both mouse and human models systems, we will
propose to investigate the mechanisms by which Tox3 regulates cerebellar histogenesis.
We propose to carry out this work in two parts. The focus of Specific Aim 1 is to interrogate the epigenetic
and transcriptomic consequences of cKO of Tox3 using multimodal single-cell RNA- and ATAC-sequencing
combined with single-cell Cut&Tag to determine genetic networks regulating VZ/RL precursors and CGC
genesis. The main goal of Specific Aim 2 is to define the role of TOX3 on murine cerebellar lineages using
inducible Cre drivers and somatic mutagenesis.

Public health relevance
PROJECT NARRATIVE The cerebellum is a critical structure for appropriate voluntary movements and is increasingly associated with element of higher cognitive function through connections with the frontal cortex. The proposed research will provide insight into the molecular regulation by which cerebellar granule cells—the most numerous neuron type in the brain—are generated. Elucidating the basic mechanisms that regulate the genesis of granule cells will provide critical insights into both developmental brain disorders and cancers arising from this lineage.